Cytoskeleton-mediated regulation of insulin secretion hot spots in pancreatic beta cells

Project Summary
Insulin secretion from pancreatic β cells is crucial to maintaining blood glucose homeostasis, allowing cells
throughout the body to take up glucose from the blood and obtain nutrients for normal cellular processes. In
type 2 diabetes, however, peripheral tissues become insulin resistant, β cells over-secrete insulin to
compensate, and eventually β cells become dysfunctional. It is therefore necessary to thoroughly understand
the mechanisms of insulin secretion in order to identify potential therapeutic targets for type 2 diabetes
treatment. Insulin secretion is known to predominantly occur at the vascular face of the β cell, at regions
termed “hot spots.” Hot spots are characterized by proteins common to the active zone of neurons as well as
proteins of cortical microtubule-stabilizing complexes and focal adhesions. Our laboratory has also found that
microtubule destabilization promotes insulin secretion specifically at hot spots. Others have shown that the
actin cytoskeleton also plays a critical regulatory role in insulin secretion. Given the known connections of
microtubules, focal adhesions, and actin with known hot spot proteins, it is likely that the interplay of these
cytoskeletal elements is essential for the hot spot organization and function. I therefore hypothesize that insulin
secretion hot spots are “secreting adhesions”: mechanosensitive subcellular domains which use cytoskeletal
regulation to accomplish directed and clustered secretion. My specific aims are to 1) characterize the
cytoskeleton networks, their interplay, and other hot spot components in β cells; and to 2) test if MT-
regulated RhoA-dependent contractility promotes clustered secretion via secreting adhesion
assembly. To address these aims, I will use high- and super-resolution fixed and live-cell imaging techniques
combined with computational analyses. Improving the understanding of hot spot identity and establishment via
the cytoskeleton will contribute to overall knowledge of insulin secretion, and potentially uncover novel targets
for diabetes therapeutics.

Public health relevance
Project Narrative Pancreatic β cells secrete insulin into the vasculature at specific locations called secretion hot spots, where various cytoskeletal and mechanosensitive proteins localize and modulate secretion levels. Since the mechanisms of this regulation are to a large extend elusive, I propose to determine details of organization of the cytoskeletal networks at hot spots and test if their molecular interplay regulates insulin secretion toward the vasculature. Understanding these molecular mechanisms may have high impact by providing potential targets for restoring normal glucose-stimulated insulin secretion in type 2 diabetes.